Developmental regulation of tendon-bone connectivity in the jaw

PROJECT SUMMARY / ABSTRACT
Integration of the jaw with the surrounding musculature is essential for speech and mastication. A
fundamental step in jaw integration begins in development, with formation of stable tendon-bone attachments
that are zonally organized into tendon, fibrocartilage, mineralized fibrocartilage, and bone. The gradient of
skeletogenic cell types within the attachment arises from attachment progenitors (APs) that, through unclear
mechanisms, interpret chondrogenic versus tenogenic signaling to acquire distinct cell fates along the tendon-
bone axis. Even less is known about APs of the jaw which, unlike their counterparts in the limb and trunk, are
derived from neural crest cells (NCC). This study tests the idea that jaw APs differentiate into a gradient of
skeletogenic cell types through a series of binary switches that are regulated by an NCC-specific mechanism.
We have found that jaw APs express graded levels of Scx, Runx2, and Sox9 depending on their position along
the tendon-bone axis. We also found that during AP differentiation a novel intermediate Scx+/Runx2+
population emerges. In Runx2+/- mice this intermediate population fails to form, and APs differentiate into
tendon over cartilage/bone. While this suggests that tripotent APs differentiate through lineage-restricted
intermediates, how APs spatially interpret signals for tendon vs. cartilage/bone to make these cell fate
decisions and whether APs always choose between one fate or the other (e.g. tenocyte vs. osteoblast) or acquire
hybrid properties (e.g. osteofibrogenic) is unknown. We recently showed that an Fgf-Notch signaling axis is
regionally deployed along the tendon-bone interface and promotes AP differentiation into tendon over
cartilage/bone. This mechanism appears NCC-specific, as loss of Fgfr2 in mesoderm-derived APs does not
alter limb attachment development. In this study, we use mouse genetics along with cutting-edge genomics to
test that, during AP differentiation, integration of Fgf and Notch signaling promotes tendon cell fate in a series
of binary switches by regulating levels of Scx, Runx2, and Sox9 transcription. In Aim1 we will use clonal lineage
tracing and scRNA-seq to determine the lineage relationship between APs and the skeletogenic cells in the
tendon-bone attachment. In Aim2, we will use conditional mouse genetics to determine how differences in
Notch signal strength along the tendon-bone axis alter AP cell fate decisions. In Aim3, we will use a
combination of mouse genetics and CUT&RUN-seq to test that Erk signaling integrates Fgf and Notch
signaling through linear and parallel mechanisms. In the linear mechanism, Erk activates Notch2 signaling by
initiating Dll1 expression. In the parallel mechanism, Erk and Notch2 independently activate the same
downstream targets genes for tendon fate including Scx. Completion of these aims will reveal a developmental
mechanism that establishes a gradient of skeletogenic cell types in tendon-bone attachments of the jaw.
Knowledge gained will guide future developmentally inspired strategies for jaw attachment repair and may
inform how jaw abnormalities develop in the FGFR2-and NOTCH2- related congenital disorders.

Public health relevance
PROJECT NARRATIVE Jaw movements in speech and mastication rely on stable tendon-bone attachments that are zonally organized into tendon, fibrocartilage, mineralized fibrocartilage, and bone; however, very little is known about how this graded attachment tissue develops. This proposal investigates a developmental mechanism that acts on tendon-bone attachment progenitors to specify tendon over cartilage cell/bone cell fate. Knowledge gained from this study will lend insights into how tendon cell fate is established, which has implications for designing developmentally inspired strategies for tendon attachment repair and understanding jaw tendon pathologies.